BioGRID: An open resource for biological interactions and network analysis

Complex physical and genetic interaction networks determine the properties of all biological systems and
underlie human development, health and disease. Decades of biological experiments have identified myriad
molecular processes that underpin specific biological processes, described in the primary biomedical literature.
More recent technological innovations combined with complete genome sequence information have led to the
development of a wide variety high-throughput (HTP) methods to generate physical and genetic interaction
data on an unprecedented scale. Because human interaction networks are often directly analogous to
networks in more tractable model organisms, it is essential that the hundreds of thousands of biological
interactions discovered across the major model organisms, as well as humans, are archived in a well-
annotated manner that provides a means for rigorous analysis and computation. To capture, integrate, and
interrogate this wealth of data from both the literature and HTP datasets, we developed the BioGRID database
as an open repository for physical and genetic interactions (www.thebiogrid.org). BioGRID contains over
2,000,000 total interactions from 75,760 publications. In 2020, BioGRID averaged 151,735 page views, 19,407
unique visitors and 7,537 file downloads per month. Our recently released Open Repository for CRISPR
Screens (ORCS), averages 8,725 page views, 1,646 unique visitors, and 268 downloads per month. In
addition, the extensive BioGRID data compendium is widely disseminated by many partner databases, meta-
databases, and software tools. Here, we propose to markedly enhance the data content, the database
architecture, and the user interface of BioGRID. We will expand the amount and types of data available
through BioGRID, with a particular focus on translating knowledge from model organism networks to humans
using ortholog mapping and a novel framework for mapping phenotypes and diseases across species. We will
significantly expand CRISPR-based genetic interactions, chemical and drug interactions, and post-translational
modifications, which we will integrate with our core physical and genetic interactions and organize around
focused curation efforts around particular biological themes. Use of text-mining algorithms and AI methods will
be extended to enhance curation rates and coverage of the proteome. User access to the large datasets in
BioGRID will be facilitated by data-rich interfaces, user-defined search and display parameters, and multiple
methods of visualization. All software will continue to be open source and engineered toward compatibility and
will be complementary with other database and software development efforts. The BioGRID will provide
interaction data and software tools to model organism databases and other interested parties without
restriction. The BioGRID resource will enable the biomedical research community to access validated
biological interaction datasets across model organisms and humans for hypothesis generation and network
analysis, and thereby further the general mission of the NIH.

Public health relevance
Narrative The BioGRID database provides an extensive collection of protein and genetic interaction data for the major model organism species and humans, with user-oriented tools to explore this information. The BioGRID facilitates better understanding of human disease by enabling inference of gene and protein function through network context and the computational comparison of these gene and protein networks in human health and disease to analogous networks mapped in model organisms. The vast amounts of data in the BioGRID are freely provided to many other databases and biomedical researchers, thus enabling both fundamental and translational research.